Combined magnetophoresis and photodynamic therapy for the treatment of TNBC

Triple negative breast cancer (TNBC) does not respond to some of the most effective therapies available for
breast cancer treatment. Even aggressive surgery, i.e. mastectomy, does not improve outcome. In fact, patients
receiving breast conserving surgery (BCS) and radiation therapy exhibit better breast cancer specific and overall
survival than patients that undergo a mastectomy, for both metastatic and non-metastatic disease. This is
thought to be due to the radiation-induced abscopal effect. Therefore, we hypothesize that and adjuvant
treatment that can both improve local regional control during BCS and enhance the abscopal effect could improve
the current standard of care. One such option is photodynamic therapy (PDT). We will utilize mesothelin-targeted
photosensitizers (PS). We have previously found that mesothelin is strongly expressed in the majority of TNBCs
and expression is highly associated with both overall and disease-specific survival.
Since most PS are lipophilic, they are often encapsulated within nanoparticles to improve their solubility and to
facilitate systemic delivery. Nanoparticles can be designed to carry high PS payloads, extend the PS circulation
time, improve tumor accumulation, and reduce off-target phototoxicity by minimizing PS uptake in healthy tissue.
However, in order to maximize the benefit of nanoparticles, new nanoformulations must be developed that
minimize the self-quenching of reactive oxygen species generation. Moreover, new strategies must be
established to help facilitate the penetration of PS-loaded nanoparticles into tumors.
Recently, we found that the amphiphilic photosensitizer Chlorin e6 (Ce6) was able to form a stable, water-soluble
coating on nanoclusters of superparamagnetic iron oxide nanoparticles (SPIONs). Due to the unique orientation
of Ce6 on the SPION surface, little to no quenching of singlet oxygen production was observed. This led to the
effective use of the Ce6-coated SPION nanoclusters (CSNs) as a PDT agent in a murine model of TNBC, leading
to a significant slowing of tumor growth. The overall goal of this proposal is to improve upon this work by
combining CSNs with mesothelin-targeting and magnetophoresis to improve the specificity, accumulation,
penetration, and efficacy of CSNs in treating TNBC. Magnetophoresis will be applied using a custom magnetic
device that can radially
profoundly
disperse CSNs from any location in a living subject. This innovative technology will
improve the ability of CSNs to reach their intended targets.The specific aims for this proposal are as
follows: Aim 1. Synthesize and characterize the physical-chemical properties of mesothelin-targeted, Ce6-coated
SPION nanoclusters (CSNs) and characterize a 2nd generation magnetic device; Aim 2. Evaluate the tumor
accumulation and penetration of CSNs in a murine model of TNBC; Aim 3. Evaluate the efficacy and toxicity of
PDT with CSNs in a murine model of TNBC.

Public health relevance
The goal of this proposal is to combine photodynamic therapy and magnetophoresis to improve the treatment of triple negative breast cancer. A photosensitizer-loaded magnetic nanoparticle will be used that exhibits minimal self-quenching of reactive oxygen species generation. Moreover, a novel magnetic device will be used to enhance the penetration of photosensitizer-loaded magnetic nanoparticles into tumors.